Immunopathogenic Mechanisms of Dry Eye Disease

Dry eye disease (DED) is a chronic immune-mediated disorder of the ocular surface, characterized by
disruption of the epithelial barrier and sustained ocular surface inflammation, which in severe cases results in
corneal ulceration and scarring. The impact of DED is significant: it is the most common ophthalmic condition
for which patients visit eye care providers, with more than 16 million US adults affected. While several
treatments have been approved by the FDA, none are ideal; all suffer from limited efficacy and/or tolerability,
reflected by the fact that less than 15% of patients with DED are using any of the approved therapeutics and
over 60% of those who start using them cease their use within 6 months due to various side effects. The
financial burden of DED is vast, with costs from productivity losses in the US exceeding $3.5 billion annually.
The work of several laboratories, including the PI’s, has revealed key insights concerning the
immunopathogenesis of DED. There is now strong evidence that T helper-17 (Th17) cells are critical
promoters of immune-mediated damage to the ocular surface. The PI’s laboratory has shown that memory
Th17 (mTh17) cells maintain disease chronicity, resulting in ocular surface epitheliopathy that persists for
many months after exposure to desiccating stress. Moreover, data from the PI’s lab show that regulatory T
cells (Treg) are defective in suppressing the Th17 response in DED. In addition, the PI’s lab has shown that
Th17 cell activation is also associated with recruitment of macrophages, critical cells of the innate immune
system, in DED; however, the mechanisms that underlie Th17-mediated recruitment of macrophages remain
incompletely understood. Despite the substantial progress that we and others have made in unraveling the
underlying immunopathogenic mechanisms of DED important questions remain unanswered.
We hypothesize that (1) T17 cells mediate ocular surface damage both directly, via secretion of effector
cytokines, and indirectly by promoting recruitment of macrophages to the ocular surface, principally through
their key effector cytokines IL-17A and IL-17F, and (2) mTh17 cells, which persist long-term, are inadequately
controlled by Treg, enabling them to induce exacerbation of disease upon reactivation. The principal
objectives of this project, as captured by our three specific aims, are to answer the following questions: (1)
What are the precise mechanisms that mediate Th17-mediated ocular surface epithelial damage? (2) How
exactly do IL-7 and IL-15 contribute to the long-term persistence of memory Th17 cells in DED? and (3) What
exactly is the interplay between Treg (dys)function and memory Th17 reactivation that contributes to disease
exacerbation in chronic DED? Finally, (4) Can low-dose interleukin-2, which can enhance Treg function,
significantly suppress mTh17 function in chronic DED? It is anticipated that this research will have significant
translational impact given the high prevalence of DED, the still limited knowledge we have regarding its
immunopathogenesis, and the scarcity of effective and well-tolerated treatments.

Public health relevance
Dry eye disease is a highly prevalent inflammatory disorder of the ocular surface. Associated with visual dysfunction, discomfort, and a heightened risk of corneal scarring and ulceration, the immunopathogenic mechanisms of this common condition are as of yet incompletely understood. We propose to determine the specific immune-based cellular and molecular pathogenic elements of chronic dry eye disease, anticipating that improved understanding of these pathogenic mechanisms will yield therapeutic targets that could be useful in optimizing the management of the millions of Americans suffering from dry eye disease.